Core A: Administration

PROJECT SUMMARY/ABSTRACT – CORE A
The Clinical Research Center is supported by Core A (Administration). Core A provides and supports
an administrative structure to integrate all scientific activities of the Clinical Research Center, with the goal of
ensuring that the Center achieves its overall objectives (Aim A.1). Toward this goal, Core A organizes and
manages Center activities and event planning, and maintains calendars of events of investigator meetings,
research seminars, and guest lectures, including preparation of itineraries and agendas for local and visiting
scientists. In addition, Core A coordinates the dissemination of research findings from the Center, including
open access of publications and other research products to the scientific and lay communities. Core A
provides administrative, clerical, and fiscal support to the Co-Program Directors and Principal Investigators of
Projects 1-4 and the Human Subjects Core (Core B) of the Clinical Research Center, so leaders of the Center
can focus primarily on academic and scientific objectives (Aim A.2). Toward this goal, Core A provides
assistance with monitoring of awards and expenditures with regular financial reporting, purchasing, record
keeping, travel logistics and reimbursements, and day-to-day administration, including equipment and facilities
records. In addition, Core A maintains the Center's connection and serves as the point of contact to key
University, College of Medicine, and Departmental entities, such as research administration and grants
accounting, human resources, physical plant, and information technology. Core A provides administrative and
financial support for the Center's External Advisory Board, which is responsible for ongoing programmatic
evaluation of the Clinical Research Center (Aim A.3). Four distinguished researchers from outside MUSC will
be selected to serve as members of our External Advisory Board after the review of the Center is completed.

Public health relevance
PROJECT NARRATIVE – CORE A The Project Narrative is included in the Overall Component, as per the Parent Announcement, PAR-19- 137, NIDCD Clinical Research Center Grant (P50 Clinical Trial Optional).